Michigan Center for Urban African American Aging Research

The Michigan Center for Urban African American Aging Research (MCUAAAR), a center comprised of the three Research 1 universities in Michigan, proposes to expand its reach and impact by mentoring junior faculty and by focusing on the unique aspects of stress and coping in older African Americans using a life course lens. Our four specific aims include (1) Increase reach through the maturation of our three-university structure; (2) Recruit and mentor 15 new junior researchers whose research will focus on unique life course experiences of stress and coping in African American older adults; (3) Enhance our established nationally recognized model for successfully engaging with urban older adult communities; and (4) Continue to build the next generation of leaders for MCUAAAR. Three cores (LAC, AnC and CLRC) and the Research Education Component (REC) are proposed in this application. We will employ an integrative approach to mentoring, entailing a structured set of activities and training across the pilot funding period:(a) Formal goals will be set at the beginning of the pilot and reviewed in monthly MCUAAAR meetings; (b) Based on the goals set, a mentoring team will be assembled to assist with research, dissemination of findings, and research translation;(c) A set of training activities in scientific writing, measurement, and community-based research partnerships will be conducted each year; (d) A formal six and twelve-month evaluation will be conducted and
shared with the MCUAAAR faculty.

Public health relevance
The purpose of the MCUAAAR is to recruit, mentor, and develop the next generation of NIH researchers engaged in research on the science and amelioration of health problems among African American older adult populations, and to engage the community of older adults in new ways to promote research participation.